Algorithmic fairness in predictive models to eliminate disparities in adverse infant outcomes: A case for race

PROJECT SUMMARY
Non-Hispanic Black infants have twice the rates of low birthweight births as non-Hispanic White infants. As
disparities in adverse birth outcomes drive disparities in infant mortality and adverse outcomes across the life
course, improving inequities in birth outcomes is a national priority. Despite this longstanding inequity, many
public and private payers are unable to address disparities in adverse infant outcomes because of a lack of
race/ethnicity data. This K01 fills a critical need for evidence-based recommendations for collection and use of
racial/ethnic data among payers to enable population health management programs to develop predictive
algorithms that could be used to reduce adverse birth outcomes. Failure to include race/ethnicity in predictive
models used for resource allocation may ultimately lead to biased algorithms that exacerbate health disparities.
Aim 1 of this study will use an algorithmic fairness framework to test multiple algorithms for developing
predictive models for low birthweight birth. In addition to testing model accuracy, predictive models will be
tested for seven measures of algorithmic fairness to assess whether having race/ethnicity improves algorithmic
fairness (e.g., equal [or better] predictive accuracy for non-White relative to White women) after applying four
fairness-enhancing approaches. This project will utilize medical claims, birth certificates, and beneficiary
information from the Arkansas All Payer Claims Database. Linkage to the birth certificates uniquely allows this
study to have race/ethnicity, which are absent in the commercial claims given lack of collection by most payers.
The seminal Institute of Medicine Report Unequal Treatment recommended collection of race/ethnicity to
mitigate disparities in health and healthcare delivery; however, it is well known that payers fear accusations of
redlining and rarely collect race/ethnicity in most states. Research on payer and provider views regarding
collection of race/ethnicity has been conducted, but similar research on the views of minority beneficiaries are
severely lacking. Aim 2 of this study will conduct racially-homogenous focus groups among Black, Hispanic,
and Marshallese women in Arkansas regarding attitudes on acceptability of collecting and using race/ethnicity
data as well as administrative aspects (e.g., when to collect the data), with an emphasis on perinatal programs.
These aims will provide an evidence-base and serve as a national model for collecting and using
racial/ethnic data with community input. Large third-party payers have the infrastructure to improve health
disparities, but lack a community-engaged approach to inform collection and use of these data to guide
development of algorithms using an equitable framework. The K01 will allow the investigator to build on her
expertise in insurance claims analysis to acquire skillsets in predictive modeling, community engagement, and
qualitative methodologies. These important skillsets will allow the researcher to achieve her long-term goals of
becoming a productive and independent researcher with a focus on identifying and mitigating factors that serve
as drivers of racial/ethnic disparities in adverse infant and maternal outcomes.

Public health relevance
PROJECT NARRATIVE Despite the longstanding inequities in rates of low birthweight births among women of minority race, many public and private payers are unable to identify and mitigate disparities in adverse perinatal outcomes because of a lack of information on race and ethnicity. Information on race/ethnicity is necessary to build adequate prediction models for allocation of resources to prevent low birthweight births. This K01 aims to provide an evidence-base for collection and use of race/ethnicity by: 1) testing whether multiple algorithmic bias reduction approaches result in fairer low birthweight predictive models than models that exclude race/ethnicity, and 2) conducting community-engaged focus groups of Black, Hispanic, and Marshallese women to develop guidelines for how and when racial/ethnic data should be collected and used by public and private healthcare payers for use in perinatal health programs.